Pathogenesis and Outcomes of SARS-CoV-2 In Utero Transmission - Immunologic and Virologic Evaluations

Importance: Despite effective vaccines, SARS-CoV-2 infection remains a major public health problem for
pregnant women and their newborns as they have increased morbidity and mortality. Studies on estimated
rates of in utero transmission are conflicting and reported on small numbers mostly limited to PCR testing at
birth. Critical Gaps include limited diagnostics to identify in utero infection and lack of understanding of factors
that impact MTCT and the pathogenesis of disease. From October 2021 through February 2023, we studied
1294 infant cord bloods for presence and level of SARS-CoV-2 antibodies. Overall, 89.9% had anti-RBD IgG,
indicating maternal vaccination and/or previous infection and 55.1% had both anti-N and anti-RBD IgG,
indicative of past infection. Fetal IgA and/or IgM antibodies to SARS-CoV-2 were found in 21.8% of 176/808
samples with anti-N, indicative of in utero transmission. The overall goal of this study is to identify newborns
with in utero SARS-CoV-2 and prospectively follow infants to identify clinical and neurodevelopment outcomes.
Aim 1: Identify newborns with in utero SARS-CoV-2 infection using a multi-faceted approach and
assess relationship with inflammation, placental infection and pathology, and immunity. Hypothesis 1:
In utero infection will be associated with elevated soluble markers of inflammation in newborn cord blood and
evidence of placental infection and dysfunction. Using cord blood we will screen 3,600 newborns for anti-N, S,
and RBD IgG antibodies (Abs) and if anti-N+ we will assess for SARS-CoV-2 specific anti-IgM and anti-IgA
abs. Maternal SARS-CoV-2 qPCR testing will be done at delivery, and if qPCR+, newborn qPCR will be
performed at 24/48 hours. Variant type will be determined by ddPCR. Newborn meconium/stool samples will
have qPCR testing. Soluble biomarkers of inflammation and immune activation will be determined. Finally,
placentas will be evaluated for pathology and SARS-CoV-2 infection.
Aim 2. Longitudinally assess for immune activation, dysregulation, and function among a subset
of infants with in utero infection and matched controls. Hypothesis 2: In utero infected infants will have
abnormal markers of inflammation, immune activation, and dysregulation that if sustained will be associated
with adverse clinical outcomes. In a subset of 100 infants with in utero SARS-CoV-2 and 50 uninfected controls
we will determine levels of CD4 and CD8 T-cell activation and dysregulation and assess for SARS-CoV-2
specific antibodies and T cell response in mother-infant dyads at birth and longitudinally. We will then correlate
with clinical and neurodevelopmental outcomes.
At the end of this project, we will have developed a comprehensive algorithm to screen and follow
newborns with in-utero SARS-CoV-2 and will have determined if there are immunologic dysfunctions
impacting clinical, developmental, neurologic, and other abnormalities that may require long-term
follow-up, treatments and/or interventions.

Public health relevance
Although there have been over 250,000 pregnant women with SARS CoV-2, there are limited data on rates of in utero transmission of SARS-CoV-2 due to diagnostic challenges. The overall goal of this study is to identify newborns with in utero SARS-CoV-2 infection and investigate clinical, virologic, and immunologic factors that may contribute to MTCT and neonatal immune and clinical outcomes. We plan a comprehensive algorithm to screen newborns for in utero SARS-CoV-2 and will determine if there are immunologic dysfunctions impacting clinical, neurodevelopmental, neurologic, and other abnormalities that may require long-term follow-up, treatments and/or interventions.